NOVEL HUMORAL AND CELLULAR BIOMARKERS OF AUTOIMMUNE DISEASES CAUSED BY IMMUNOTHERAPY

Immunotherapy has transformed the treatment landscape for a wide range of human malignancies. Immune
checkpoint inhibitors (ICIs) are monoclonal antibodies that block the immune regulatory “checkpoint” receptors,
the Cytotoxic T-Lymphocyte Associated Protein 4 (CTLA-4), Programmed Cell Death 1 (PD-1), or its ligand PD-
L1. ICIs produce durable responses in many patients. However, coupled with their success, these treatments
commonly evoke a wide range of immune-related adverse events (irAEs), such as diabetic ketoacidosis (DKA)
or thyroid disease, appearing to occur more frequently than originally expected. Immunotoxicity from cancer
immunotherapy occurs in up to 90%, whereas autoimmune endocrine diseases occur in approximately 50% of
patients treated with antibodies to CTLA-4 and/or PD-1/PD-L1. These irAEs can be serious or even life-
threatening, such as autoimmune type 1 diabetes (T1D) presenting in DKA, and primary adrenal insufficiency
caused by autoimmune adrenalitis. A recent study showed a marked increase of ICI-related autoimmune
diabetes; reported in over 50% of the patients, with half of these patients presenting in DKA (50.2%). Thus,
reliable biomarkers are needed to accurately stratify the risk of irAEs in patients who are candidates for these
therapies (Aim I); these biomarkers may point to novel molecular pathways that could be targeted to prevent
irAEs caused by immune checkpoint blockade (Aim II). Specifically, we will utilize the state-of-the-art single-cell
platforms to investigate and characterize the comprehensive phenotypic and functional analyses of systemic
cellular networks in patients with ICI-induced endocrinopathies. Our studies are greatly facilitated by the Baylor
College of Medicine Immunotoxicity Working Group. Understanding the immunologic factors and the biomarkers
associated with ICI-mediated inflammatory toxicities will be useful for the identification and early treatment of
ICI-induced irAEs, and it may provide new insights into the pathoetiology and treatment of autoimmune endocrine
diseases.

Public health relevance
PROJECT NARRATIVE Immune checkpoint inhibitors can result in long-lasting clinical responses in a variety of advanced or metastatic malignancies, but approximately half of patients receiving these drugs develop autoimmune endocrinopathies. Our proposal brings together expertise in three complementary areas such as endocrinology, autoimmunity, and oncology. The outcome of this investigation will provide mechanistic insights into immunotherapy-related adverse events and may provide the groundwork for understanding how to limit the toxicity of immunotherapy as well as improving treatments of autoimmune endocrine diseases.